Regulation of Silica-induced Lung Injury by Plasminogen Activator Inhibitor-1

Occupational or environmental exposure to respirable crystalline silica dusts is a major cause of lung diseases
worldwide. This occurs in mining, sandblasting, foundry work, agriculture, construction and more recently in oil
and gas extraction, which involves hydraulic fracturing. Exposure to silica is expected to rise in the US because
of mechanical handling of millions of pounds of crystalline silica (“frac sand”) used as a proppant to maintain
cracks and fissures created by hydraulic fracturing of shale or rock oil deposits and processing of granites or
quarts in flooring and countertops. However, the fundamental mechanisms that contribute to silicosis remains
elusive. Understanding the underlying pathogenesis of silica-induced lung injury (sLI) or silica-induced
pulmonary fibrosis (sPF) or silicosis could have broad implications on workers’ and public health. Increased type
II alveolar epithelial cell (A2C) damage mediated by the tumor suppressor protein, p53 via upregulation of
plasminogen activator inhibitor-1 (PAI-1) is strongly implicated in sLI. Further, increased expression of a pro-
inflammatory cytokine; interleukin-17A (IL-17A) during sLI, augments monocyte chemotactic protein-induced
protein 1 (MCPIP1). Although, multiple studies underscore the importance of IL-17A, MCPIP1 and PAI-1, and
dysregulated autophagy in the pathogenesis of silicosis, there is limited information on the interrelationships
between increased IL-17A, MCPIP1, PAI-1 and control of autophagy.
Our proposal will address this critical gap of knowledge. We will use a range of molecular and novel
interventional approaches that include the use of transgenic mice to address our working hypothesis; that IL-
17A-mediated induction of MCPIP1 and PAI-1 expression promotes aberrant autophagy; in particular
mitophagy and thereby apoptosis in A2Cs, which is central to the pathogenesis of sLI and silicosis. Our
objective is to establish how changes in IL-17A-induced expression of PAI-1 by MCPIP1, regulates autophagy
and apoptosis in A2Cs and thereby silicosis. We will determine if targeting of this pathway with a 7-mer deletion
fragment of caveolin-1 scaffolding peptide (CSP7) mitigates sLI and remodeling.
Our Specific Aims are: 1) To elucidate the role of IL-17A-induced PAI-1 in the regulation of autophagy in
a mouse model of sLI and determine whether silicosis can be reversed by treatment with CSP7. 2) To
determine if IL17A-induced PAI-1 mediates mitophagy in mice with sLI and its mitigation by CSP7
treatment. This project will advance the field by elucidating how IL-17A mediated induction of MCPIP1, PAI-1
and autophagy reduces A2C viability, resulting in lung injury and fibrosis due to silica exposure. This proposal
will expand our understanding of the pathogenesis of silicosis and test a new interventional approach to mitigate
sLI and decrease its long-term morbidity.

Public health relevance
Occupational exposure to silica dust is a significant cause of lung disease worldwide and silica-induced lung injury or silicosis is caused by inhalation of free crystalline silica dust and is incurable and irreversible. We will elucidate how the interaction between proteins such as IL-17A, MCPIP1, PAI-1 and autophagy contributes to the pathogenesis of silicosis. We will test interventions that target this pathway to protect against lung injury and fibrosis induced by silica dusts.